IMMUNOLOGICAL MECHANISMS OF NEPHRITIS IN CHILDHOOD SLE

DESCRIPTION: (Adapted from the Investigator's abstract): Childhood systemic lupus erythematosus (SLE) differs from the disease in adults by a higher prevalence of nephritis. The investigators hypothesize that this higher prevalence of nephritis is due to several types of nephritogenic autoantibodies that occur concurrently in the childhood form of SLE. Two major candidates for these autoantibodies are those directed against dsDNA which have long been recognized to play a role in adult lupus nephritis and autoantibodies to ribosomal "P" protein which have not been reported previously to be associated with either adult or pediatric lupus nephritis. Aside from recent preliminary clinical and animal data that support a role for anti-P in lupus nephritis, both anti-dsDNA and anti-ribosomal "P" antibodies have been found to contain subsets that directly bind and injure cells in culture. According to the investigators, this antibody-mediated, in vitro cell injury phenomenon could be a surrogate for their immunopathogenic potential in vivo. The investigators propose to define the pathogenic potential of the autoantibodies in individual patients by affinity purifying their autoantibodies and by studying their interaction with various cell types in culture and the effects on cell function and viability. In preliminary studies, they have reproduced previous work by showing that some human anti-dsDNA antibodies injure cells by a complement dependent mechanism at the cell surface, and others penetrate the cell, localize in either the nucleus or the cytoplasm, and like anti-P, inhibit protein synthesis. The investigators will correlate these immunopathogenetic properties in vitro with the patients' clinical status. They propose to expand their studies of the idiotypic regulation of these antibodies in patients with anti-P antibodies. Parallel studies in adults suggest that, like children, the presence of both anti-dsDNA and anti-P antibodies greatly increase the risk of active nephritis. The investigators also have preliminary data that anti-P may be enriched in human glomerular eluates and propose to expand these studies. Lastly, they propose to develop an animal model to assess the nephritogenic potential of induced anti-P antibodies. They hope that these studies would expand perspectives on the immunopathogenesis of nephritis in both children and adults with SLE.